Intein technology to deliver CFTR to CF airway using AAV

The aim of our proposal is to deliver intact, functional CFTR using AAV into CF patient cells to relieve the
symptoms of CF regardless of the CFTR mutations that they carry. Previous approaches for delivering CFTR
using AAV have been conducted using truncated CFTR constructs due to the cargo size limitation of AAV. This
approach was not successful, potentially due to dysfunction of the truncated protein. To circumvent this limitation
of AAV and deliver a full-length intact CFTR into cells, we have employed intein technology. The CFTR gene is
split into two constructs and attached to coding segments for intein, and delivered using two AAVs (a dual AAV
approach). This delivered gene is then translated in the cell, and the resulting protein halves are spliced together
by inteins to create a functional, full-length CFTR protein. We have tested this dual AAV system using primary
airway epithelial cells from six CF patients who do not respond to CFTR modulators and have seen significantly
improved CFTR function in vitro. In this proposal, we will optimize delivery of this split CFTR, dual AAV system
in airway epithelial cultures from people with CF that do not respond to modulators. This system will also be
applied to a CF-relevant mouse model to study efficiency and durability of gene transduction. Since AAV is
clinically approved for gene therapy to deliver a therapeutic gene (e.g., Hemophilia gene therapy) and a dual
AAV approach was also successfully applied in a recent clinical trial for deaf patients lacking functional otoferlin
(OTOF), we expect in the future that our dual AAV with intein may be used to restore CFTR activity in patients
with CF, which is especially important for those CF patients who do not respond to CFTR modulators.

Public health relevance
The proposed research is relevant to public health because it will develop AAV carrying CFTR to alleviate the symptoms of cystic fibrosis (CF) patients, especially the patients who do not respond to CFTR modulators. This approach, utilizing inteins to package a large gene into dual AAVs, will also provide an avenue of genetic therapy delivery into the airway for other large genes. Thus, the proposed research is relevant to the mission of the NIH to acquire new knowledge that will help to diagnose and treat human diseases.